Synergistic anti-fouling coating and minimal systemic antibiotic injections for combating periprosthetic infections

PROJECT SUMMARY/ABSTRACT
Periprosthetic infections (PPIs) occur in 1-4% of primary total joint replacement and up to 30% of revision
arthroplasty and are difficult to prevent or treat due to the tendency of bacteria, especially Staphylococcus
aureus (S. aureus), to colonize and form biofilms on implant surfaces and to invade the surrounding bone
matrices. Conventional antibiotic prophylaxis and treatments do not adequately address this challenge. We
recently showed that anti-fouling zwitterionic polymers grafted from Ti6Al4V intramedullary (IM) implants, when
combined with a single systemic injection of vancomycin, effectively inhibited S. aureus colonization on implant
surfaces and PPI in murine femoral canals, significantly outperforming either treatment alone. Here, we aim to
facilitate the clinical translation of this promising synergistic anti-PPI strategy by engineering a robust anti-
fouling block copolymer dip-coating as an off-the-shelf product for metallic implants, and an effective and safe
synergistic antibiotic prophylaxis regimen for sustained protection during primary implant insertion and implant
revision, respectively, against methicillin-sensitive and methicillin-resistant (MRSA) S. aureus PPIs. In Aim 1,
high-molecular weight polymethacrylate block copolymers with anti-fouling zwitterionic sidechains and metal
surface-binding sidechains are prepared by sequential Reverse Addition Fragmentation Chain Transfer (RAFT)
polymerization and copper-catalyzed azide-alkyne cycloaddition (CuAAC). Taking advantage of the excellent
control over the degree of polymerization by RAFT and the high-fidelity CuAAC modification of sidechains, the
respective block lengths and chemical nature and spatial density of metal alloy surface-binding residues are
modularly altered to identify an optimal copolymer composition and dip-coating protocol to achieve consistent
and stable anti-fouling coating on Ti6Al4V that can sustain flow wash, sterilization and over-the-shelf storage.
Coated surfaces are characterized by water contact angels, x-ray photoelectron spectroscopy, and resistance
to non-specific protein adsorption and bacterial colonizations in vitro. In Aims 2 and 3, the top anti-fouling dip-
coating chosen in Aim 1 is applied to Ti6Al4V IM pins and examined, along with synergistic antibiotic
prophylaxis, for the efficacy and safety in achieving long-term inhibition of PPI and recurrent PPI caused by
methicillin-sensitive S. aureus or MRSA following the insertion of primary and revision implants in rats,
respectively. The degree of PPI or recurrent PPI as a function of pin coating and the timing/frequency of
synergistic antibiotic prophylaxis are longitudinally monitored by complete blood counts and µCT quantification
of cortical bone thickening, and by endpoint quantification of bacteria on the retrieved pin, torsion test and
histology/electron microscopy characterizations of explanted femurs over the course of 6 months. Long-term
safety of the coating is examined by both femoral histology and systemic organ pathology in the uninfected
control. Success of this study will identify an optimal dip-coating composition and synergistic antibiotic
prophylaxis regimens to effectively combat PPI and recurring PPI, respectively, thereby establishing their
clinical relevance as a new anti-PPI strategy and advancing them to the next stage of their clinical translations.

Public health relevance
PROJECT NARRATIVE Infections associated with metallic implants occur in 1-4% of primary total joint replacement and up to 30% of revisions. Current prophylactic local delivery of high-dose antibiotics is known for cytotoxicity and could risk the development of bacterial drug resistance while prolonged systemic antibiotic treatments are often ineffective in eradicating established infections. The proposed prophylactic metallic implant surface coating is designed to discourage bacterial colonization on implants while substantially improving the efficacy of a minimal safe dose of systemic antibiotic injection in rooting out implant associated infections. Page 5